Impact of COVID-19 on implementation and outcomes of VA's Life-Sustaining TreatmentDecisions Initiative

Proactive goals of care conversations (GoCCs) conducted in advance of clinical deterioration are a hallmark of
high-quality, patient-centered care. When done well, GoCCs allow healthcare providers to tailor end-of-life care
to patient values and improve key outcomes for patients, caregivers, providers, and the healthcare system.
Given the need for structures and processes to promote GoCCs, the VA National Center for Ethics in Health
Care implemented the Life-Sustaining Treatment Decisions Initiative (LSTDI) at all VA facilities in 2018 to
promote standardized documentation of GoCCs for Veterans at high risk of clinical deterioration. As of early
2020, proactive GoCCs remained vastly underutilized. The onset of the COVID pandemic reinforced the
need for and importance of GoCCs to guide end-of-life care, acting as a catalyst for innovations to
LSTDI implementation. In response to the pandemic, guidelines and lay media instilled a new urgency among
patients and providers to proactively discuss and document GoCCs. Many sites both within and outside of VA
developed innovations to facilitate proactive GoCCs, including outreach to high-risk patients (e.g., those with
dementia), holding GoCCs by telehealth (a new modality for these sensitive discussions), and tasking and
training outpatient providers previously unreached by the LSTDI with conducting GoCCs. [At least 40 VA
facilities have increased outpatient GoCCs in 2021 compared with pre-pandemic rates.]
[Yet it remains unknown how these sites increased and maintained GoCC rates, or whether COVID-catalyzed
LSTDI implementation innovations improved GoCC rates at the expense of GoCC quality or equity. Our
hypothesis is that some facilities prioritized outpatient LSTDI implementation during the pandemic, achieving
sustainable increases in both reach and quality of GoCCs without exacerbating disparities in GoCCs among
Black Veterans. From close evaluations of LSTDI implementation at selected sites, we will identify sustainable
innovations catalyzed by the pandemic that can be spread across VA to improve LSTDI implementation and
delivery of high-quality, equitable, patient-centered end-of-life care, even after the pandemic recedes.]
Our sequential explanatory mixed methods study is designed to [comprehensively assess the long-term
impact] of the COVID pandemic on LSTDI implementation and the frequency, quality, and equity of GoCCs.
We begin with time series analyses to examine how COVID affected LSTDI implementation across VA
facilities, with attention to [sustained] changes in reach to Veterans and adoption by providers (Aim 1). We will
then leverage time series and proportional hazard analyses to assess quality and equity of outpatient GoCCs,
as determined by documentation of National Quality Forum preferred practices in LSTDI notes (Aim 2a), and
length of time from GoCC to death, a marker of proactive advance care planning (Aim 2b). Finally, in Aim 3, we
will interview Veterans, providers, and leaders from [10] sites purposively selected based on Aims 1 and 2
findings to identify best practices to improve [and maintain frequency, quality, and equity of GoCCs, with
special attention to approaches to engage Black Veterans and patients with dementia]. Findings will inform a
playbook to improve quality, equity, and sustainability of LSTDI implementation.
The changes wrought by the pandemic to VA healthcare delivery created an unprecedented opportunity to
identify innovations, challenges, and unintended consequences in implementing the LSTDI, as well as
outcomes of GoCCs on quality and equity of end-of-life care delivered before, during, and after COVID. This
study is designed to leverage the unique circumstance and sense of urgency created by the pandemic and will
produce a usable deliverable: an implementation playbook capturing best practices and innovations catalyzed
by the pandemic. This work is strongly supported by our partners in the National Center for Ethics in Health
Care and the Office of Primary Care to help spread the LSTDI, and it is of central importance to achieving the
VA mandate to conduct GoCCs to improve the quality, equity, and patient-centeredness of end-of-life care.

Public health relevance
Proactive goals of care conversations (GoCCs) are a hallmark of high-quality, patient-centered care, allowing healthcare providers to tailor end-of-life care to patient values. When done well, GoCCs improve outcomes for patients, family/caregivers, providers, and healthcare systems. Unfortunately, proactive GoCCs remain vastly underutilized. The emergence of the COVID-19 pandemic in March 2020 and its disruption to healthcare emphasized the need for explicit GoCCs to elicit patient goals and preferences. This study will assess how the pandemic disrupted implementation of VA’s Life-Sustaining Treatment Decisions Initiative (LSTDI), a standardized approach to conducting and documenting GoCCs. We will evaluate how COVID affected rates of GoCCs during [and after] the pandemic and catalyzed innovations to the LSTDI. We will identify [sustainable] best practices to improve frequency, quality, and equity of outpatient GoCCs that remain relevant post- pandemic and create a highly usable playbook to improve LSTDI implementation at low-performing VA sites.